Social Media Concerns Related to Emotional Experience in Naturalistic Settings: SCREENS

PROJECT SUMMARY/ABSTRACT
Rising rates of internalizing symptoms, including depression, anxiety, and suicidal ideation, in youth in the US
represent a public health crisis. In 2024, 40% of youth experienced a past-year persistent sadness or
hopelessness and 29% reported past-month poor mental health (i.e., depression, anxiety, or stress), while
suicide has consistently ranked in the top three causes of death for youth aged 13-18. Coinciding with the
increase in internalizing symptoms, social media use has rapidly grown, but the link between social media use
and mental health is not well understood, especially in at-risk, clinical populations. Moreover, most research on
the topic has been cross-sectional, lacking information about the impact of social media use on proximal and
longer-term outcomes for internalizing symptoms. It also often fails to consider both ways in which social media
use may be harmful and protective. There is a critical need for longitudinal research on social media’s relationship
with internalizing symptoms in youth and risk and protective factors for individuals. Therefore, we propose a
study in response to RFA-MH-25-206 (Bidirectional Influences Between Adolescent Social Media Use and
Mental Health) that uses longitudinal and intensive monitoring on multiple timescales to identify how social media
use and experiences are linked to internalizing symptoms in a sample of at-risk youth. The proposed study will
enroll N=100 youth aged 13-18 years recruited from the University of Texas Southwestern Node of the ongoing
Texas Youth Depression and Suicide Research Network (TX-YDSRN) Registry study. The Registry enrolls youth
with depression and/or suicidal thoughts or behaviors, so participants have high rates of internalizing symptoms.
At baseline, internalizing symptoms and social experiences (i.e., victimization) will be collected via clinical
interview and self-report; subsequently, internalizing symptom self-report measures will be collected monthly for
six months. Participants will complete ecological momentary assessments (EMA) twice daily during the first
month, with questions on real-time positive and negative Emotional Responses to Social Media, internalizing
symptoms (i.e., depression, anxiety, and suicidal ideation), and positive and negative in-person interactions.
Objective social media use data (i.e., use duration), along with EMA, will be collected via a smartphone app
(mHealth). Using these data, this proposal aims to: (1) Investigate how amount of social media use and
positive/negative experiences impact internalizing symptom trajectories over six months and (2) Determine social
context factors impacting the relationship between social media use amount and experiences and internalizing
symptoms. Throughout the project, the established TX-YDSRN youth advisory board (N = 15) will be consulted
to inform study approach, data interpretation, and dissemination of study findings. This proposed R21 will
generate pilot data for a future R01 application aimed at state-wide investigation of social media use and mental
health in Texas youth. Results of this project have the potential to inform clinical interventions and prevention
programs to promote youth mental health in the context of social media.

Public health relevance
PROJECT NARRATIVE Rising rates of internalizing symptoms, including depression, anxiety, and suicidal ideation, among youth in the United States have coincided with the rapid growth of social media use. To address the limitations of current research, which has mostly been cross-sectional and fails to consider both positive and negative factors related to social media use, the proposed research aims to (1) investigate how amount of social media use and positive/negative experiences impact internalizing symptom trajectories over six months and (2) determine social context factors impacting the relationship between social media use amount and experiences and internalizing symptoms. This proposed R21 will generate pilot data for a future R01 application aimed at state-wide investigation of social media use and mental health in Texas youth, which will have the potential to inform clinical interventions and prevention programs to promote youth mental health in the context of social media.